Clinical Core

Identifying homogenous subgroups within the greater population of cLBP is critical for developing new diagnostic
paradigms and personalized treatment strategies. In order to identify these subgroups traits from all of the
different domains must be assessed. The UCSF REACH Clinical Core will collect data from a large prospective
and granular cohort of cLBP patients to: 1) delineate the complex interplay among socioeconomic, biologic,
pathophysiologic, biomechanical, and psychological characteristics that contribute to cLBP; and 2) identify
clinically relavent, mechanistically based phenotypes that can be used to define personalized treatment
protocols.
In support the overall goal of the BACPAC Research Program and the goals of UCSF REACH, the Clinical Core
proposes the following Specific Aims: Aim 1. Enroll and follow a prospective, longitudinal Clinical Cohort, n=400,
capable of supporting deep phenotyping of cLBP patients based on combined biopsychosocial variables; Aim
2a. Enroll a large digitally based, cross-sectional, Digital Cohort, n=5000, that will allow testing and adoption of
machine learning techniques that can lead to novel cLBP phenotyping algorithms; Aim 2b. Develop an
engagement platform, called eREACH, to incentivize patient participation in the Digital Cohort by providing
education, self-monitoring and self-help tools with the goal of supporting digital interventions for cLBP in the
future; Aim 3a. Develop a large central cLBP Data Warehouse (DW) to organize, integrate, maintain, and archive
data from several diverse data sources, including all measurement data collected from the Clinical and Digital
cohorts; this DW will be a pivotal data resource for the UCSF REACH Research Project, the Informatics Core,
other members of the BACPAC consortium, and future cLBP researchers; Aim 3b. Provide support/reporting to
the Observational Study Monitoring Board

Public health relevance
Per RFA, Project Narrative is not required.